Novel antiviral activities of tumor necrosis factor-alpha

DESCRIPTION (provided by applicant): Tumor necrosis factor-α (TNFα) has potent, direct antiviral activity but has not been exploited as an antiviral therapy because of its systemic toxic effects. We have observed that primary human liver cells and hepatoma cells treated with low levels of TNFα are resistant to infection with the hepatitis C virus (HCV) in vitro. This effect is dependent on TNFα interaction with its receptor and is seen in the absence of detectable IFN? or IFN? gene expression. Sindbis virus, an alphavirus, infects Huh-7 hepatoma cells and is insensitive to TNFα pretreatment. However, TNFα synergizes with IFN? to block Sindbis virus infection. We propose to use state-of-the-art techniques to identify key mediators of TNFα's antiviral effects alone and in combination with IFN?. We propose three Specific Aims. In the first Aim, we will test the requirements for signal transduction through the major pathways activated by TNFα binding to its receptor, using pharmacologic inhibitors as well as dominant negative regulators of TNFα signal transduction. In the second Aim, we will use novel virological and cell biological tools to define the stages in HCV infection that are inhibited following TNFα treatment. In the third Aim, we will use microarray and next-generation sequencing approaches to define the effects of TNFα on the transcriptome, identify candidate genes that may mediate the development of an antiviral state in TNFα- treated cells, and test the importance of these genes by knockdown and overexpression studies. The long-term goals of this research are to identify specific cellular pathways that mediate TNFα's antiviral activity, and to determine whether it is possible to isolate these activities from TNFα's systemic toxic effects.

Public health relevance
Hepatitis C virus infection remains a major public health problem and can cause liver cancer and cirrhosis, and is the leading indication for liver transplantation in the United States and Europe. We have found that tumor necrosis factorα (TNFα) can make certain cells resistant to infection with hepatitis C virus as well as Sindbis virus, an alphavirus. However, TNFα is highly toxic and is not suitable as a treatment for viral diseases. We propose to use a variety of techniques to determine how TNFα mediates its antiviral activity with the hope of isolating the antiviral effects of TNFα from its toxic effects.